Interdisciplinary Training for Vascular Surgeon Scientists

PROJECT SUMMARY/ABSTRACT
The design and implementation of improved therapies for vascular diseases are dependent on a better
understanding of the basic physiological processes involved. Such processes are biologically complex, with
elements at the molecular, cellular, organ system, and integrative levels. Research into the pathophysiology of
vascular diseases and their treatments will be strengthened by training vascular surgeon-scientists in
investigative methods allowing them to develop and maintain state-of-the-art laboratory skills and pursue novel
strategies for cure and prevention. The goal of the University of Florida - Interdisciplinary Training for Vascular
Surgeon Scientists (ITVSS) Program is to provide the training required for success as future academic surgeons
and scientists in the field of vascular surgery. Graduates of our training program will be prepared to join an
academic surgical faculty, conduct independent research, compete for grant funding, and provide translational
surgical expertise at their institutions.
At the core of our program are the following specific aims: 1) provide a 2-year integrated training program for
four surgery residents and/or fellows to create a career pathway for conducting mechanistic and clinically
relevant translational research in vascular disease; 2) implement a training program that promotes a learning
cycle of concrete experiences, active experimentation, reflective observation, and abstract conceptualization; 3)
closely monitor and track trainee-related experiences and outcomes that will serve as a foundation for evaluating
the current status of the program and for making continuous quality improvements; 4) create a culture for
professional excellence based on enhancing rigor, reproducibility and transparency in research and establishing
a career trajectory as leaders in the surgical delivery of vascular care; and 5) maintain the research-focused,
career trajectory developed during the fellowship by promoting a culture of scholarly activity, foster interaction
among the ITVSS trainees, mentors, and Directors during the completion of clinical training.
Unique aspects of the ITVSS Program include: 1) a high-density of NIH-funded surgeon-scientists providing
the necessary training environment and role models; 2) use of a team mentoring approach, where each trainee
has an identified research and clinical mentor; 3) trainee engagement in an “Immersive Training Experience”
that is outside of their research focus area, to provide the foundation for conducting team-based, multi-
disciplinary research; 4) support by a robust vascular research portfolio that offers trainees high-quality
experiences in basic, translational, outcomes, and clinical research; and 5) institutional backing that provides
administrative and supplemental financial resources to maximize the training experience.

Public health relevance
PROJECT NARRATIVE A decline in the number of physician-scientists will impact our nation’s capacity to produce innovative research for patients with vascular disease. Attracting the brightest minds into an academic research career is critical. This project creates a 2-year integrated training program for surgery residents and fellows to develop a career pathway for conducting mechanistic and clinically relevant translational research in vascular disease.